Modeling cancer risk and environmental and socio-spatial exposures using residential histories

In many studies on the risk of disease, investigators analyze the spatial patterns of health outcomes and evaluate
residential environmental exposures at the time of study enrollment in hopes of identifying potential causal
environmental factors. However, for cancers with long latencies like bladder cancer and non-Hodgkin lymphoma
(NHL) residential locations many years prior to diagnosis are important for determining where and when relevant
environmental exposures occurred in mobile study populations. Many environmental factors are distributed
unevenly over space and time and several decades may have elapsed between exposure to a relevant risk factor
and diagnosis. While some investigators have begun to consider residential histories in studies of cancer, a
number of research challenges remain. Statistical methods are currently lacking for modeling cumulative spatial
risk of cancer over time using residential histories in epidemiologic studies. There is also a need for methods
that estimate environmental and socio-spatial exposure effects over time while modeling cumulative spatial risk.
Exposure data are increasingly becoming multivariate and there is a need to develop statistical methods for
handling multivariate exposures such as chemical mixtures over time. In the consideration of residential histories,
more investigators are proposing to use public record databases such as LexisNexis to acquire historic
residential locations for study subjects. However, it is currently unknown what impact using residential histories
from public record databases in place of subject-reported residential histories has when studying environmental
cancer risk over time. Measurement error and therefore bias could result from using public record databases
particularly going several decades back in time. In this project, we aim to develop a comprehensive set of
methods that incorporate residential histories into cancer studies to estimate both cumulative spatial risk and
health effects of many environmental and socio-spatial exposures over time. We will apply these methods to the
New England Bladder Cancer Study and the NCI-SEER NHL study to better understand environmental factors
for bladder cancer and NHL. We will also assess the impact of using residential histories from public record
databases on the ability of methods to identify spatial areas of risk and estimate environmental and socio-spatial
exposure effects. The expected outcomes of this research will be 1) new statistical methods for estimating
cumulative spatial risk and health effects for many environmental and socio-spatial exposures over time, and 2)
identification of areas of significantly elevated risk over time for bladder cancer and NHL risk, 3) estimates of
effects for mixtures of historic environmental and socio-spatial exposures and bladder cancer and NHL risk, and
4) an assessment of using residential histories from public record databases to estimate historic exposure effects
and detect areas of elevated cancer risk. The methodological approaches developed will be applicable to many
studies of cancer and environmental risk. In addition, the findings from the assessment of public record database
residential histories will be useful for many investigators considering using them in environmental risk studies.

Public health relevance
Project Narrative In many studies on the risk of disease, investigators analyze the spatial patterns of health outcomes and evaluate residential environmental exposures at the time of study enrollment in hopes of identifying potential causal environmental factors. However, for cancers with long latencies residential locations many years prior to diagnosis are important for determining where and when relevant environmental exposures occurred. In this project we will develop statistical methods that incorporate residential histories to estimate the effect of historic environmental and socio-spatial exposures and identify areas of elevated cancer risk over time.